THE COVID 19 SERVICES CATALYZE TRANSLATIONAL RESEARCH FINDINGS INTO PUBLIC HEALTH CHANGES TO ADDRESS THE NOVEL CORONAVIRUS PANDEMIC THROUGH IMPLEMENTA

Abstract
These funds are used to provide support for the NCI AIDS & Cancer Virus Program (ACVP) and overhead/management support for all the AIDSresearch within the $425M FY2013 NCI budget at the NCI-Frederick. This overhead/management support includes appropriate allocations of thefollowing areas: facility maintenance; building support; utilities; scientific library; computer and statistical services; environmental, health and safetyprograms; subcontract staff; repository services; advanced technology and laboratory animal science program support; and general FederallyFunded Research and Development Center (FFRDC) Contract administration. The ACVP, headed by Dr. Jeff Lifson, is an integrated,multidisciplinary program that pursues basic and applied studies aimed at improving our understanding of AIDS-associated viruses, including studiesintended to facilitate the improved diagnosis, prevention and treatment of HIV infection and AIDS, and AIDS related tumors, particularly thoseassociated with other viruses such as KSHV. The Program consists of six independent but highly interactive research Sections headed by PrincipalInvestigators, whose work spans from fundamental molecular virology through in vitro studies, to in vivo studies in non-human primate (NHP)models, to international viral epidemiology.